TAS::75 0849::TAS SYSTEMS FOR AUTOMATED STORAGE, ANALYSIS, AND REPORTING OF OBJE

The Contractor will develop an open-source software service that makes it extremely easy for a researcher to gather and analyze high-resolution activity and accelerometer data.